Mechanisms of spreading proteinopathy in Lewy Body Dementia

PROJECT SUMMARY
One
adequately
alpha-synuclein
diagnosis,
as
pathology
major obstacle to alting neurodegeneration i n Lewy body dementias is a lack of mammalian models that
display the range of neuropathological changes found in the human disease. Although aggregated
Lewy pathology occurring within specific neurons in the cortex i s required to make this
in the vast majority of cases, there is coexistent beta-amyloid plaque pathology in the same regions
Lewy pathology. The relevance these multiple proteinopathies to the formation and spread of Lewy
throughout the nervous system is currently unknown. The
h
Unni lab has been working for many years
to understand the role of cortical alpha-synuclein pathology in synucleinopathies, including pioneering in vivo
multiphoton imaging approaches that can measure the formation and spread of Lewy pathology and the
longitudinal cell fates of individual neurons with and without Lewy inclusions over a period of many months.
Recently, we and our collaborator Randall Woltjer have discovered that the presence of beta-amyloid
pathology greatly increases the formation and/or spread of Lewy pathology in mouse cortex after seeding with
alpha-synuclein preformed fibrils. In this proposal, our team will understand how the presence of beta-amyloid
plaques and tau neurofibrillary tangles accelerate the formation and spread of alpha-synuclein Lewy pathology
throughout the nervous system, and the potentially critical role played by brain-resident immune cells,
microglia, in this process. The results of this work will push forward our ability to understand and develop new
treatments for Lewy body dementias.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to understand how beta-amyloid plaque, tau neurofibrillary tangle and alpha-synuclein Lewy body pathology interrelate in Lewy body dementias. This understanding will allow us and the field to develop new therapies for these dementias that target these interacting proteins.